The Contribution of Eye-Hand Coordination Impairment to Functional Deficits in Stroke

PROJECT SUMMARY
Current standard of care in post-stroke upper-limb motor training has measurably reduced impairment and
increased both active range of motion and movement quality. However, such improvements rarely generalize
to performance gains for activities of daily living and functional independence. One of the hallmarks of
functional arm movement is the seamless integration of visual inputs and limb control, mediated by the ocular
motor system. However, this important foundation of functional performance and recovery has not been
incorporated into stroke rehabilitation. This gap exists because not enough is known about basic eye-hand
coordination (EHC), associated neuroanatomy, and how EHC is affected by stroke. Our preliminary data
provide strong evidence that specific eye-hand coordination deficits can result from MCA stroke. The eye-hand
coordination system is currently not addressed in neurorehabilitation research or clinical rehabilitation because
of a lack of understanding of the mechanisms that underlie this coordination and how such mechanisms may
be affected by stroke. This proposal will examine the neuroanatomical foundations of eye-hand coordination
and how these networks are affected by middle cerebral artery stroke. The results are expected to provide a
foundation for improved understanding of eye-hand coordination in functional deficits and functional recovery,
post-stroke. This advanced understanding should provide the basis for a line of translational research that will
lead to new clinical assessments and interventions to address eye-hand coordination deficits in stroke
survivors. This knowledge may, in turn, address the current gap between motor recovery and functional
recovery in stroke survivors with eye-hand coordination dyscoordination (EHdC). Our primary hypotheses are
that MCA stroke can produce deficits in EHC through damage to specific frontoparietal circuits, and that
changes in these circuits can predict functional recovery following stroke. We will address these hypotheses
through the following two Aims. In Aim 1, we will determine the contribution of EHdC to motor recovery and
function in MCA stroke. Hypothesis: MCA stroke produces EHC deficits that interfere with functional upper-limb
recovery and functional independence. Aim 2: To identify microstructural changes to frontoparietal networks
related to motor recovery and EHdC in MCA stroke. Hypothesis: Microstructural integrity in MCA stroke will
relate to dyscoordination (mistiming). The findings from this proposal will detail the functional neuroanatomy
underlying eye-hand coordination, and the functional implications of lesions in this system to functional
performance. This foundation of knowledge will provide for a translational line of research to determine
contributions of eye-hand coordination to functional deficits and functional stroke recovery.

Public health relevance
PROJECT NARRATIVE Stroke is the leading cause of serious long-term disability in the US, often resulting in persistent sensorimotor deficits that limit functional independence; although current standard of care in physical rehabilitation can substantially reduce motor impairment in the paretic limbs, such gains often do not generalize to improved functional independence. One of the most important, yet neglected areas of study in stroke is the role of eye- hand coordination in functional performance and functional deficits; this proposal will examine the mechanistic foundations of eye-hand coordination and how these mechanisms are affected by middle cerebral artery stroke. The proposed research is foundational for translational research to address the role of eye-hand coordination mechanisms in rehabilitation and functional recovery of stroke survivors; this line of research will eventually provide a basis for developing new clinical assessments and targeted interventions to translate gains in motor recovery to functional independence.